Administrative Core

PROJECT SUMMARY
The goals of the Administrative Core are to provide all projects within the Lymphoma SPORE with
centralized leadership and administrative support, and to ensure effective communication among all
Projects and Cores. Through this work, the Administrative Core will ensure the Program’s overall objectives
are being met. To achieve this goal, Core leaders Drs. Helen Heslop and Malcolm Brenner will arrange
internal group meetings, including a monthly investigator meeting, executive committee meetings, and
invited research lectures. The Core will oversee the overall fiscal and budgetary management of the
SPORE and assist each project and core leader to achieve their goals, with a particular focus on assisting
budgetary planning. Over the last 14 years of funding, this Core has monitored each project with input from
the Executive Committee and Internal and External Advisory Boards, and modified projects and
incorporated new directions as necessary. For the current proposal, the Administrative Core leaders will
ensure continued SPORE oversight by convening meetings of the Scientific Advisory Board, which consists
of both internal and external investigators with expertise in the field and assessing and implementing their
recommendations. The Core also coordinates input from patient advocates and liaises with the Baylor
Office of Diversity to ensure diversity in projects, the Career Enhancement Program (CEP), the
Developmental Research Program (DRP), and all clinical research conducted under the SPORE. This Core
will also coordinate the administration of the Developmental Research and the Career Enhancement
Programs to ensure that the objectives of these programs are being met. This Core has the discretionary
funds to support new research opportunities or unexpected costs. Finally, the Administrative Core will
communicate with the NCI program staff and encourage and facilitate collaboration with other NCI
translational initiatives.

Public health relevance
NARRATIVE The Administrative Core supports the leadership of the overall Lymphoma SPORE to facilitate cooperation and communication between all Projects and Cores for the successful completion of the proposed research. This Core organizes meetings to monitor progress and promote collaboration and obtains external advice on program performance from Internal and External Scientific Advisory Boards. The Administrative Core also co-ordinates input from patient advocates and the Baylor College of Medicine Office of Diversity.